Causal Molecular Mechanisms Linking Drinking Water Metal Exposures to Cardiometabolic Disease

Project 4 Summary
Chronic exposure to metals and metalloids (hereafter metals) is detrimental to human cardiovascular and
metabolic health. Native Americans living in the Northern Plains consume well water with elevated levels of
arsenic (As) and uranium (U), common Superfund site contaminants. Metal exposures in these populations are
epidemiologically linked to high rates of cardiovascular disease and diabetes. However, strategies to prevent or
treat the disease burdens related to groundwater metal exposures have been limited by poor understanding of
the molecular mechanisms of individual and combined metal exposures. To fill this gap, Project 4 of the Columbia
University Northern Plains Superfund Research Program (CUNP-SRP) will establish human-relevant mouse
models of chronic metal exposures and cardiometabolic disease to comprehensively evaluate such mechanisms.
We will leverage genetically engineered mouse models to investigate developmental vulnerability, tissue and
cellular level effects, and specific molecular mediators of exposure–outcome relationships. We will expose mice
to environmentally relevant concentrations of As and/or U in addition to well water samples containing a naturally
elevated As/U mixture that people in the Northern Plains consume (collected in Project 1). We will then determine
the cardiometabolic effects of these exposures, compare early-life to lifelong exposures, and determine how
dietary folate mitigates As toxicity. Aim 1 will define health impacts and developmental vulnerability of
early-life or lifelong exposure to As/U in drinking water in genetically engineered mice. Mouse
cardiometabolic health will be evaluated longitudinally with a battery of clinical, histological, behavioral, and
functional tests with a focus on atherosclerosis, hypertension, adiposity and diabetes, in the context of a
hyperlipidemic model. Moreover, this aim will generate a biobank of As and/or U exposed animal tissues for
future studies, creating an expansive resource for collaborative research projects with other SRP centers. Aim
2 will profile mouse multi-omics biomarkers altered by early-life or lifelong exposure to As/U in drinking
water. DNA methylation, gene expression, and the metabolome will be profiled in mouse blood, liver, and
pancreas samples collected in Aim 1 to reveal molecular markers of metal exposure and cardiometabolic
disease. Molecular signatures in mice will be compared to Project 3 human molecular signatures to identify
conserved pathogenic mechanisms as well as the utility of blood biospecimen markers to represent target organ
pathologies not typically available in human observational research. Aim 3 will evaluate the human-relevant
potential for and mechanisms of dietary folate supplementation to reduce As toxicity. Since laboratory
mice rapidly eliminate consumed As via methylation, we will use mice that instead metabolize As similarly to
humans. Through these three aims, we will establish a valid animal model system for causal discovery science
and to test therapeutic interventions to tackle the extensive and disproportionate disease burden attributable to
groundwater metal exposures affecting tribal populations in the Northern Plains.

Public health relevance
Project 4 Narrative Arsenic and uranium are major contaminants at Superfund sites, and exposure to these contaminants can partly explain the excess burden of cardiometabolic disease affecting Native American communities in the US. Project 4 will determine the physiological and molecular pathways linking arsenic and uranium exposures to cardiometabolic disease phenotypes using tractable transgenic mouse models. This study provides detailed and expansive insight into the developmental and life-long influences of these metals exposures and create a novel experimental system to test interventions to protect highly exposed populations in the US Northern Plains.